Task Order No.62 - Pre-Meeting Planning Activities for Cancer Intervention and Surveillance Modeling Network (CISNET)

Pre-Meeting Planning Activities for Cancer Intervention and Surveillance Modeling Network (CISNET)